Mechanisms of Toxicity Induced by EWS/FLI1 Overdose in Ewing Sarcoma

PROJECT SUMMARY/ABSTRACT
EWS fusion oncoproteins are critical drivers in a number of malignancies, including the pediatric solid tumor
Ewing sarcoma, the second most common pediatric cancer involving bone. In the case of Ewing sarcoma, the
fusion of EWS to the ETS transcription factor FLI1 generates an oncogenic pioneer transcription factor that alters
a distinctive set of regulatory elements to control oncogenic gene expression. The impact of repression of the
EWS/FLI1 fusion with approaches such as shRNA, CRISPR, or targeted protein degradation is now well
described and known to be deleterious to Ewing sarcoma cells. In contrast, the potential of EWS/FLI1 overdose
is just newly described and has been understudied. We recently discovered a powerful and novel selective
dependency in Ewing sarcoma on TRIM8, an E3 ubiquitin ligase. Remarkably, TRIM8 controls the levels of
EWS/FLI1 protein, and its inactivation leads to an increase in EWS/FLI1 protein levels that is not tolerated by
tumor cells. Ewing sarcoma cells must thus carefully regulate the levels of EWS/FLI1 within a narrow “just right,”
“Goldilocks” range. Either too little or too much fusion protein is lethal. The mechanisms that control optimal
levels of EWS/FLI1 and that mediate cell lethality from high levels of the fusion protein are unknown. We expect
that defining these mechanisms will reveal important principles of Ewing sarcoma biology that may also be
applicable to other EWS fusion proteins, and that this knowledge may point to new therapeutic strategies. The
overall goal of this proposal is thus to determine the mechanisms of EWS/FLI1 induced toxicity following TRIM8
loss in Ewing sarcoma through three aims. The gene regulation properties of EWS/FLI1 are highly dependent
on the formation of biomolecular condensates, which in turn require the phase transition properties of the EWS
disordered prion-like domain. Similarly, TRIM8 has been described to have a role in condensate formation. Thus,
in Aim 1, we will determine the relationship between TRIM8 and EWS/FLI1 biomolecular condensates with the
hypothesis that that EWS/FLI1 regulation by TRIM8 is dependent on condensate formation and that, in turn, loss
of TRIM8 leads to changes in condensates. In Aim 2, we will determine the impact of TRIM8 loss on epigenetic
states in Ewing sarcoma including 3D interactions. In Aim 3, we will identify the mechanisms by which EWS/FLI1
overdose is toxic. Based on gene expression and ORF screening data, we will lead this aim with the hypothesis
that the glutamate receptor GRM2 mediates toxicity downstream of EWS/FLI1 overdose. New therapeutic
approaches distinct from traditional cytotoxic chemotherapy and local control measures are needed for patients
with Ewing sarcoma as little progress has been made in treating high-risk patients over several decades. These
proposed studies exploring an innovative strategy of oncogene overdose have potential for future translational
impact in addition to revealing basic underlying mechanisms of disease.

Public health relevance
PROJECT NARRATIVE Little progress has been made in the treatment of patients with EWS fusion driven cancer, including Ewing sarcoma, a pediatric solid tumor driven by the EWS/FLI1 fusion oncoprotein. In this proposal, we will evaluate the novel hypothesis that Ewing sarcoma tumors are susceptible to oncogene overdose through decreasing TRIM8, the E3 ligase for EWS/FLI1. We will determine the mechanisms governing the EWS/FLI1 and TRIM8 interactions, including condensate formation; the impact of TRIM8 repression on epigenetic states; and test the hypothesis that the glutamate receptor GRM2 mediates toxicity downstream of EWS/FLI1 overdose mediated by TRIM8 repression.